NOSI to The Role of Estrogen in the Neurobiology of Eating Disorders: A Study of Cognitive Flexibility and Reward in Eating Disorders

Abstract
Eating disorders (EDs) typically onset in adolescence at a time of gonadal hormone changes and rapid brain
development. EDs characterized by extreme dietary restriction and/or excessive exercise (ED-R/E) and high
drive for thinness are associated with cognitive inflexibility, reduced reward responsiveness, and altered
reward valuation, which contribute to illness maintenance and poor outcomes. Hypoestrogenemia is common
in ED-R/E (~60%), and in other conditions has been linked to cognitive inflexibility and altered reward
responsiveness and valuation. Clarifying the link between estrogen status, Cognitive Flexibility, Initial
Response to Reward and Delay, and ED pathology may facilitate identification of novel treatment
targets to improve outcomes via an experimental therapeutics approach. Our preliminary data indicate: (i)
abnormalities in RDoC domains of Cognitive and Positive Valence systems in hypoestrogenic adolescents/
young adults (independent of weight) compared to normo-estrogenic controls, and (ii) that hypoestrogenemia
is associated with reduced Cognitive Flexibility and Initial Response to Reward (neural response to palatable
food images), altered Delay (increased preference for larger delayed over immediate smaller rewards), and
increased ED pathology. Estrogen deficiency may thus play a key mechanistic role in maintenance of ED-R/E
by acting on these RDoC domains. Importantly, hypogonadal adolescents/young women are commonly treated
with estrogen replacement for other (e.g. bone) outcomes, and data from our team and others demonstrate
that estrogen replacement also improves Cognitive Flexibility, Initial Response to Reward and Delay. Further,
our data show that (i) long-term estrogen replacement improves ED pathology and food intake, and (ii)
improved Cognitive Flexibility following estrogen replacement predicts improved ED pathology. Published work
in other hypogonadal states shows that even short-term (8-12 weeks) estrogen/estrogen agonist administration
can alter cognitive flexibility and reward processing. It is now critical to examine whether estrogen deficiency
contributes to dysfunction across Cognitive and Positive Valence RDoC domains in ED-R/E, and
whether correcting estrogen deficiency improves improves ED pathology via its impact on these
domains. To fill this gap, we propose using physiologic estrogen replacement as a mechanistic probe in ED-
R/E. We will randomize 120 hypoestrogenemic females with ED-R/E (ages 16-26) to a 12-week challenge of
physiologic estrogen or placebo to evaluate: effects on RDoC constructs (Updating, Representation and
Maintenance i.e. Cognitive Flexibility; Initial Response to Reward; and Delay) at 8 weeks; ED pathology at 12
weeks; and determine whether 8-week changes in RDoC subconstructs mediate the 12-week improvement in
ED pathology. We hypothesize that in ED-R/E, correcting estrogen deficiency will improve Cognitive Flexibility,
Initial Response to Reward and Delay, and ED pathology; and that improvement in ED pathology will be
mediated by changes in these RDoC subconstructs.

Public health relevance
Project Narrative Adolescence and young adulthood are often a time for the onset of eating disorders, as well as a key window of neurocognitive development and hormone changes. Estrogen dysregulation is common in eating disorders and is associated with impaired cognitive flexibility and altered reward responsiveness and valuation, which in turn, may play a mechanistic role in the onset and course of eating disorders. This proposal utilizes physiologic estrogen as a probe, studying its role in cognitive flexibility, reward responsiveness and valuation, and in turn, eating disorder psychopathology, in eating disorders.